Administration

ADMINISTRATION: ABSTRACT
The goal of Administration is to operationalize the University of Florida Health Cancer Center (UFHCC) strategic plan, allocating and managing the resources required for collaboration across the institution, with other Cancer Centers, and with our community partners to enable novel, interdisciplinary cancer research impacting our catchment area. To achieve this goal, UFHCC Administration provides administrative leadership, oversight, and support for the research initiatives of the UFHCC members, promoting and coordinating the intra- and inter- programmatic activities of this matrix center within the University of Florida, and supporting a culture of team-based success. UFHCC Administration provides operational leadership, organization, and financial oversight in support of the activities of the director, senior leadership, research program leaders, shared resources directors, and all UFHCC members. Administration supports 147 UFHCC members in 3 research programs from 40 departments in 11 University of Florida colleges. UFHCC Administration leverages the expertise of its experienced staff centrally located to function in an efficient and value-added manner in support of the mission of the center. The areas of responsibility and functions of Administration include management of 1) strategic planning and evaluation activities; 2) fiscal oversight and allocation of institutional funds, including philanthropy; 3) faculty recruitment and retention; 4) UFHCC membership process; 5) UFHCC shared resources; 6) UFHCC research programs, seminars, symposia, and scientific program retreats; 7) space allocation; 8) pre- and post-award activities of complex grant mechanisms; and, 9) UFHCC pilot grant processes. Key accomplishments of UFHCC Administration since 2016 include a) supporting the strategic recruitment of 58 new members (45 external), that include 39 early-stage investigators, resulting in a >55% increase in cancer-relevant peer-reviewed direct cost research funding from $21M in 2016 to $32.6M in 2021; b) developing and implementing an integrated electronic data warehouse (EDW) for strategic planning and reporting purposes; c) establishing the UFHCC Office of Community Outreach and Engagement and launching community engagement efforts including Project CONTINUITY, linking community residents to cancer screening and care; d) reconfiguring the Biostatistics and Quantitative Sciences Shared Resource as a UFHCC-managed shared resource; and, e) engaging with other Florida-based cancer centers via the Florida Academic Cancer Center Alliance in collaborative research projects, meetings, and co-sponsored retreats. Future plans include implementing the new strategic plan, Momentum 2027, enhancing EDW reporting capabilities, managing CCSG reporting and renewal, assisting the 2 developing shared resources to become fully operational within the next 3 years, and measuring the impact of the UFHCC on cancer incidence and mortality in the catchment area.